Modeling Product Selectivity in Electrocatalytic Carbon Dioxide Reduction Using Scaling Relationships

Project Summary
The Wood-Ljungdahl (WL) pathway is a CO2 fixation pathway that relies on two different CO2 reducing
enzymes — formate dehydrogenase (FDH) and carbon monoxide dehydrogenase (CODH) — to ultimately
convert CO2 to biomass through formate and carbon monoxide. Biology has successfully evolved catalysts for
the reactions in the WL-pathway that feature remarkable activity and selectivity that is envied by the
pharmaceutical and commodity chemicals industries, where the efficient utilization of CO2 as a C1 building block
is desirable. Despite this, attempts to design structural models of these enzymes for homogenous electrocatalytic
CO2 reduction have been unsuccessful. A more comprehensive understanding of the enzymes found in the WL-
pathway and the design of better CO2 reduction catalysts will require a better understanding of how the intrinsic
properties — reduction potential (E1/2) of the catalyst , pKa and concentration of acid, and degree of intermediate
stabilization by secondary sphere effects — direct product selectivity.
In order to better understand how the properties of these enzymes lead to disparate selectivity, molecular
“thermodynamic-kinetic scaling relationships” for the electrochemical CO2 reduction reaction (CO2RR) will be
developed. “Scaling relationships” are defined as a correlation between thermodynamic variables with kinetic
outcomes such as turnover frequency or selectivity. These scaling relationships will be used to determine how
perturbations to tunable thermodynamic variables (catalyst E1/2, acid pKa, etc.) affect selectivity outcomes.
Monitoring the selectivity as a function of these variables will enable the building of a selectivity model. In
addition, we will determine how secondary sphere effects alter the selectivity through hydrogen bonding and
electrostatic interactions in analogy to similar effects found in enzyme active sites. Last, we aim to address how
electric fields — which are increasingly implicated in enzymatic mechanisms of action — alter the selectivity of
CO2RR through the study of hybrid electrodes featuring an anchored molecular CO2 reduction catalyst.
Prof. Mayer and Yale University have provided an excellent environment to not only conduct my proposed
research but to grow as a scientist. The research I am proposing to conduct under the mentorship of Prof. Mayer
will give me the knowledge to address a wide range of complex problems. During my burgeoning postdoctoral
tenure, I am continuing to develop my professional skills by communicating my work through presentations and
writing, and to continue mentoring students as I've done throughout my career but with a new perspective.
Additionally, Yale University has surrounded me with faculty that are knowledgeable in many of the areas I aim
to be. For example, Prof. Patrick Holland's incredible reputation for ligand design and Prof. Sharon Hammes–
Schiffer's leadership in PCET theory will undoubtedly be beneficial resources for my proposed molecular CO2
electroreduction. Under the guidance of Prof. Mayer and Yale University, I will continue to develop my identity
as an independent scientist.

Public health relevance
Project Narrative The autotrophic Wood-Ljungdahl pathway found in bacteria and archaea uses two enzymes to fix CO2 to formate and carbon monoxide en route to complex biomolecules. In order to determine the intrinsic properties that lead to selectivity in these enzymes, we will explore the origins of selectivity in molecular CO2 reduction electrocatalysts using systematic perturbations to the catalytic system and thermodynamic-kinetic scaling relationships. The findings in this study will both help further our mechanistic understanding of CO2 reducing enzymes and also inform the next generation of CO2 reduction electrocatalysts.